NANOMANIPULATOR INTERACTIVE SCANNING PROBE MICROSCOPES

Towards the ideal user interface for scanning probe microscopes. We have continued to improve both system capabilities and user interface. In order to provide the widest range of forces between imaging and modification modes, we have developed Tapping/contact mode operation. This places the AFM in non-contact tapping mode for imaging and feeling the surface, then switches it into contact mode for modification. We have incorporated multiple input data sets (near-field optical data, surface-tip adhesion data) as additional inputs that are registered with topography. These additional data sets are displayed as surface color when scanning and surface friction when feeling. We will incorporate lateral force, compliance and surface conductance as additional input channels; surface texture, roughness, stickiness, firmness, and sound as additional output channels. Our goal is to provide many simultaneous non-conflicting channels of information from the instrument to the user, in real time during modification and exploration experiments. We have ported the system from high-end, specially-designed hardware onto commonly-available devices, building a complete Nanomanipulator system in the SPM lab from off-the-shelf components. At the same time, we continue to explore using the advanced capabilities of state-of-the-art hardware, maintaining remote connections to the laboratory over a high-speed network. This meets our goal as a trailblazing facility that explores the most useful future techniques on today's most advanced hardware, developing a system which becomes affordable for widespread use in several years. Close, daily collaboration between computer scientists as tool builders and physical scientists as tool users ensures that the right tools are built, and that the tools become available outside our facility. The system has been presented at both computer science and physics conferences, describing both the user interface work and the science done using the system. Reports published in the proceedings and international speaking engagements spread word of the system usefulness to the broader scientific community.